ADMINISTRATIVE CORE

This Core provides administrative support for all other cores and projects and serves to integrate the program project as a whole. The core promotes scientific interactions among the investigators and monitors progress in accomplishing the goals of the program project. It also interacts with relevant University, departmental, and business offices. The Program Director, Executive Director and support staff represent the Core personnel. The Program Director chairs the Executive Committee that guides policy and scientific decisions and includes all principal leaders of the program project research team. An External Advisory Committee provides expertise relevant to program project goals The specific aims of Core A: Administration are: 1. Coordinate and integrate all cores and projects and monitor the effectiveness of the program project in carrying out its goals 2. Provide administrative and budgetary support to the Cores and Projects and ensure appropriate utilization of funds in all program project activities. 3. Arrange for periodic external review and advice regarding program project goals and progress.